Venous Thrombosis After Traumatic Injury

PROJECT SUMMARY
Venous thromboembolism (VTE) continues to be a major health problem with over 500,000 VTE events in the
US annually. Venous thromboembolism costs more than $8 billion per year to our health care system and causes
more than 100,000 deaths per year in the US alone. Venous thromboembolism is particularly problematic in
patients who experience trauma. Despite administration of chemoprophylaxis to trauma patients during
hospitalization, about 5% of patients still develop symptomatic VTE prior to discharge, and, more alarmingly, 40
- 60% of patients who develop symptomatic VTE, do so after discharge. An accurate assessment of traumatic-
injury based coagulopathies remains dependent on unavailable basic scientific knowledge needed to address
the National Institutes of Health (NIH) initiative of defining the “role of laboratory monitoring…to help better define
those at risk of bleeding and thrombosis.” To understand the etiologies of trauma-induced venous
thromboembolism, a comprehensive approach that assesses plasma coagulation factor activities, platelet
reactivity, and endothelial function within the context of pre-trauma patient characteristics (sex, BMI, smoking
etc.) and “real-time” blood studies at the time of trauma is required”. Obtaining integrated lab and clinical data
from a diverse trauma patient population is not readily feasible in a single investigator’s laboratory or site. The
long-term goal is to develop novel predictive, diagnostic and treatment strategies that identify “at risk” individuals
for VTE or bleeding soon after trauma. Our Central Hypothesis is that clinically significant thrombosis requires
the integrated dysregulation of NETosis, thrombin generation, endothelial injury, and von Willebrand factor-
platelet dysfunction. Our collaboration embodies all of the elements needed to improve the quality of care of
trauma patients. The investigators are from multiple health-related professions and this leverages experiences
and knowledge from different, but related disciplines. Our collaboration also encourages and fosters scientific
inquiry with the scientific expertise that will create and disseminate new knowledge and applications. Finally, the
team science approach that we have culminated is expected to provide for the highest quality of care and
improvement of trauma health outcomes.

Public health relevance
PROJECT NARRATIVE Clotting complications such as deep vein thrombosis and pulmonary embolism (collectively termed as venous thromboembolism [VTE]) are a major health problem, with over 500,000 annual events in the United States alone. There is lack of knowledge of why some patients develop these complications, especially after traumatic injury, and others do not. Our goal is to evaluate novel laboratory tests and therapeutics that will define risk of VTE and that do increase risk of bleeding.